Oral Microbiomes and Dental Caries in a Human Immunodeficiency Virus Infected Population

PROJECT SUMMARY
Childhood caries is a serious public health problem affecting the immediate and long-term quality of life of both
the child and its family. Recent studies have shown an increased prevalence of caries in HIV-infected children.
Furthermore, HIV-infected children on highly active antiretroviral therapy (HAART) show decreased salivary
flow rates, which likely predispose them to caries. These findings reinforce the need for evidence based
prevention and treatment for the promotion and maintenance of oral health. It is now well documented that the
human microbiome is intimately associated with our health, and studies focusing on the gut microbiome have
shown adverse community shifts for HIV+ individuals, where normal commensals are depleted and pathogens
enriched. Preliminary studies of the impact of HIV infection on the oral microbiome have shown that the
distribution of certain species of bacteria and fungus in saliva is different between healthy and HIV+ individuals.
Dental plaque communities show a dramatic shift in taxonomic composition as a tooth transitions from health
to disease that includes a decrease in potentially beneficial bacteria that produce basic compounds and an
increase in highly acidogenic and aciduric taxa. The objective of this project is to provide a detailed taxonomic
and gene expression characterization of dental plaque communities at different stages of caries for children
subject to HIV exposure, infection, and treatment. To accomplish this, we will take advantage of a unique
cohort of HIV infected children in Nigeria. Here, we will take an innovative approach that (i) combines the 16S
rRNA gene with two additional loci that provide species level resolution for the Streptococci, Neisseria, and
fungi, and (ii) incorporates detailed taxonomic profiling in the construction of a reference pan-genome for
metatranscriptomics. In Aim 1, for HIV-infected children on HAART, HIV exposed but uninfected children, and
unexposed and uninfected (HUU) children, we will utilize metagenomics (high throughput amplicon
sequencing) to profile the taxonomic composition of plaque samples obtained from teeth that represent six
progressive stages of caries. In Aim 2, using plaque samples obtained from teeth that represent six
progressive stages of caries, obtained from HIV-infected children on HAART and unexposed/uninfected
children we will utilize metatranscriptomics to measure changes in community gene expression to determine
how bacteria and fungal metabolic pathways involved in caries are influenced by HIV infection and treatment.
We anticipate that these aims will yield the first detailed insight into how HIV exposure, infection, and treatment
affect the ecology and development of caries in children. Ultimately, this knowledge will translate into improved
prevention and intervention stratergies that could potentially mitigate an increased risk of caries in an HIV
infected child.

Public health relevance
PROJECT NARRATIVE Childhood caries is a serious public health problem affecting the immediate and long-term quality of life of both the child and its family, and recent studies have shown an increased prevalence of caries in HIV-infected children. Making use of a large and unique cohort of HIV+ children in Nigeria, the research to be conducted here will apply metagenomics (amplicon sequencing) and metatranscriptomics to provide detailed microbial taxonomic and gene expression profiles from dental plaque representing six progressive stages of caries. Ultimately, the knowledge gained from this research will translate into improved prevention and intervention stratergies that could potentially mitigate an increased risk of caries in an HIV infected child.